Immunoengineering cellobiose as a fuel source for T cells

Abstract
Glucose levels are low in the microenvironment of solid tumors due to the voracious nature of tumor
metabolism, impeding the function of tumor-infiltrating T cells that might otherwise control tumor growth. T
cells require glucose for energetics, cytokine production, proliferation, and cytotoxicity. Infusing additional
glucose into patients is not a viable solution as it would feed only the tumor and further starve T cells. Adoptive
cell therapies (CAR-T cells) often fail in solid tumors because of this metabolic hurdle created by tumors.
Cellobiose, a polymer of glucose found abundantly in plant matter in the form of cellulose, has the potential
to serve as a carbon and energy source. However, mammalian cells cannot catabolize cellobiose. Our preliminary
data show that engineering two proteins into T cells allows them to make use of cellobiose. Thus, we already have
a working system set up to engineer T cells to have an exclusive source of glucose to fight tumors. We showed
this glucose source is completely inaccessible to tumors.
Our long-term goal is to translate this capability to T cells that are engineered for cancer immunotherapy
(e.g., CAR-T cells). Our team includes T-cell immunologists at UCLA assisted by expert colleagues in immune
metabolism and cancer immunotherapies. In this R21 proposal, we will in Aim 1, characterize as cellobiose is
hydrolyzed to glucose, and trace its carbons into various metabolic and biosynthetic pathways and provide
energy. We test the capacity of cells to use cellobiose-derived glucose through state-of-the-art metabolomics in
293 cell lines and primary T cells. In Aim 2, we test toxicity and pharmacokinetics to prepare for melanoma
experiments in mice. We test in a proof-of-concept experiment the ability of T cells to fight mouse melanomas,
using transduced pmel TCR transgenics and CAR-T cells that target melanoma.
By adding cellobiose metabolism to engineered T cells, we offer a new fuel source and a synergistic approach
that significantly potentiates cancer immunotherapies.

Public health relevance
Narrative Solid tumors consume most of the glucose in their environment, leaving T cells starving for this critical fuel they need to proliferate and kill cancer cells. Here we propose to engineer two enzymes into T cells that allows them to thrive on a new glucose source, the sugar called cellobiose, that tumors cannot use. For this exploratory proposal, we propose here proof-of-concept experiments in mouse melanoma as we head towards translation to human cancers.